Examining the Relevance of Social Network Characteristics and Cognitive Aging: A Causal Inference Study

PROJECT SUMMARY/ABSTRACT
The study embarks on an exploration of the influence of Social Network Cognitive Buffers (SNCBs), comprising both
quantifiable and subjective facets of social interaction, on cognitive aging and their potential link to Alzheimer's Disease
and Related Dementias (AD/ADRD). Leveraging the unique context of the COVID-19 pandemic, the research aims to
assess the cognitive effects of increased social isolation in older adults and the possible recuperative outcomes of
restoring social ties post-pandemic. Guided by two primary objectives, the analysis utilizes longitudinal data from the
Health and Retirement Study to distinguish between objective social isolation and subjective feelings of loneliness. First,
the study examines changes in cognitive aging due to the fluctuation of SNCBs among individuals aged 65 and above,
shedding light on the role of social networks in cognitive health. Secondly, it delves into the diverse impacts of reduced
social contact and loneliness on cognitive outcomes, probing into the protective potential of varied social connections.
In particular, the research focuses on uncovering the mechanisms most responsible for acting as cognitive buffers,
exploring the long-term cognitive effects of the pandemic on older adults, and investigating universal mechanisms, such
as the value of social network diversity in reducing cognitive decline. By employing causal inference methodologies and
panel models, the study aims to pinpoint the specific SNCBs that significantly affect cognitive health. The anticipated
findings could highlight the potential benefits of reestablishing social ties in later life stages, contributing not only to the
understanding of conditions like AD/ADRD but also to the broader field of aging research. The study's multifaceted
approach represents a vital step in advancing the knowledge of social network effects on cognitive health and has the
potential to guide public health strategies for older adults. Additionally, it serves as a significant milestone in the
development of the candidate, furthering a promising career in aging research.

Public health relevance
PROJECT NARRATIVE My research will investigate the causal link between robust social networks and cognitive aging in the context of Alzheimer's Disease and Related Dementias, advancing the understanding of the impacts of social isolation intensified by the COVID-19 pandemic. Its contribution to public health and society will be in elucidating the nuanced relationship between feelings of loneliness, objective social isolation, and cognitive performance in older adults. Additionally, I’m interested in exploring how the quality of social interaction may uniquely impact cognition by exploring the difference between familiar ties and novel ones. Lastly, a major goal of this work is to further understand the mechanisms through which social networks affect cognitive function, distinguishing between the effects of engagement within familiar social circles and interactions with a more diverse set of acquaintances. Given this insight, the results hold the potential to inform interventions aimed at reintroducing robust social networks post-pandemic, leading to improved cognitive outcomes and overall well-being in the aging population.